Neuropeptidergic mechanisms underlying hedonic feeding behavior

PROJECT SUMMARY
The motivation to seek food is one of nature’s strongest driving forces and is essential for the
survival of any species. Mammals often show an increased motivation to consume calorie-dense
food, which is evolutionarily favorable as it allows them to store excessive calories in the form of
fat to cope with future food scarcity. Many humans, however, live in conditions where food is
readily available and abundant, and the evolutionary drive to take advantage of calorie-dense
foods can become maladaptive and promote obesity. The role of the neuropeptide neurotensin
(NTS) in feeding and obesity has been studied for decades; however, largely based on its
expression in the lateral hypothalamus. We found that NTS is highly expressed in a central node
of the brain’s reward system, the lateral nucleus accumbens (NAcLat). NAcLat neurons project to
the ventral tegmental area (VTA) and we have previously demonstrated that optogenetic
stimulation of the NAcLat→VTA pathway promotes reward-related behaviors. Yet, the function of
NTS in the NAcLat→VTA pathway is unknown. In preliminary experiments, we found that
optogenetic stimulation of NAcLat terminals in the VTA strongly increased hedonic feeding in mice
that are kept on a regular chow diet, but not in mice that are on a high-fat diet (HFD). While the
feeding produced by optogenetic stimulation of NAcLat→VTA neurons was restored when HFD
mice were placed back on a regular diet for an extended time, optogenetic stimulation of
NAcLat→VTA neurons never affected feeding behavior of regular chow. Importantly, optogenetic
induced hedonic feeding behavior was prevented by infusion of an NTS receptor antagonist into
the VTA suggesting a potential role for NTS in the NAcLat→VTA pathway for hedonic feeding
behavior. Based on our preliminary data, we propose to study NTS signaling in the NAcLat→VTA
pathway in the context of hedonic feeding behavior and determine pre- and post-synaptic
mechanisms of how prolonged HFD may affect this circuitry to promote behavioral and metabolic
adaptations. To do this, we have established a collaboration with Lin Tian (Max Planck Florida),
who has developed a novel neurotensin sensor that allows us to measure NTS release in vitro
and in vivo. We will also collaborate with the lab of Csaba Földy (University of Zurich) to perform
patch-seq experiments and analyze diet-induced adaptations in gene expression and cellular
physiology. Because many functions of the brain reward circuitry are conserved between mice
and humans, our work to understand diet-induced changes in the mouse brain will provide an
important foundation for the development of future obesity treatments.

Public health relevance
PROJECT NARRATIVE Our study seeks to provide fundamental insight into the role neuropeptides in the brain’s reward system for hedonic feeding behavior. To achieve this, we will employ molecular and viral tools in combination with electrophysiology, fiber photometry or optogenetics in mice that consume hedonic foods while on a regular or high-fat diet. The proposed study may lead to the identification of molecular and circuit-level targets that can guide the development of novel treatments for obesity in humans.